Molecular mechanisms linking cerebrovascular disease pathologies to AD/ADRD in older adults

ABSTRACT
CVD pathologies are a major contributor to AD/ADRD in older adults. However, the underlying mechanisms
are unknown. To elucidate the underlying mechanisms, interrogating molecular genetic data including
transcriptomes and proteomes is required. Prior studies identifying mechanisms underlying Alzheimer’s
disease (AD) have examined multi-omics data at gray matter tissues where AD and other neurodegenerative
pathologies predominate. However, it is mainly white matter tissue that is damaged by CVD pathologies and
risk factors. In addition, white matter changes have also been observed in relation to AD pathology
accumulation such as amyloid-β deposits. Since some genetic risk factors express differently in different tissue
environments, it is necessary to complement prior studies with generation of multi-omics data extracted from
white matter to identify mechanisms underlying contribution of CVD and AD pathologies to AD/ADRD. The
overall objective of this proposal is to identify molecular mechanisms underlying contribution of CVD
pathologies to AD/ADRD clinical phenotypes. To accomplish this objective, we will leverage clinical,
pathological, and omics data of two studies, the Religious Orders Study (ROS, P30AG072975) and the Rush
Memory and Aging Project (MAP, R01AG017917). We will complement the currently available ROSMAP omics
data obtained from dorsolateral prefrontal cortex (DLPFC) with transcriptomic and proteomic data of deep
frontal white matter obtained by this proposal. This proposal is based on the following preliminary findings. 1)
some DLPFC proteins that were associated with AD/ADRD clinical phenotypes were also associated with CVD
pathologies. 2) White matter disruption in deep frontal area was associated with faster cognitive decline in
participants with vascular cognitive impairment. We extend these findings by examining the following specific
aims. In Aim 1, we will measure RNA transcription levels at deep frontal white matter (DFWM). Then, we will
use computational biology approaches including clustering methods and Bayesian networks to identify RNAs
underlying contribution of CVD and AD pathologies to AD/ADRD. In Aim 2, we measure DFWM proteins and
examine them using clustering methods and Bayesian networks to identify DFWM proteins underlying
contribution of CVD pathologies to AD/ADRD. In Aim 3, we will use other computational biology approaches to
identify colocalized signals between DFWM RNA transcriptions (or proteins) data and publicly available GWAS
summary statistics for ischemic stroke and Alzheimer’s dementia to link genetic risk factors to the molecular
mechanisms. All three Aims will be done using RNA and proteins quantified in 2 separate dataset: a discovery
dataset of 300 participants and a validation dataset of 200 participants. In Aim 4, we will replace DFWM RNA
transcriptions and proteins with those of DLPFC to identify if RNAs and proteins underlying contribution of CVD
and AD pathologies to AD/ADRD are different in gray vs. white matter.

Public health relevance
NARRATIVE Alzheimer’s disease and related dementia (AD/ADRD) are the most common cause of dementia in older adults, and cerebrovascular disease (CVD) pathologies are a major contributor to AD/ADRD. However, the mechanisms underlying contribution of CVD pathologies to AD/ADRD are not clear. In this project, we will examine genes, RNAs, and proteins in the brain to identify molecular mechanisms linking CVD pathologies (and other pathologies including AD) to AD/ADRD that will provide new targets for prevention and treatment of AD/ADRD in millions of Americans at risk of it.